2022 Hypothalamus Gordon Research Conference

PROJECT SUMMARY
We have organized a new Gordon Research Conference (GRC) on the topic of the hypothalamus, a highly
complex brain structure found in all vertebrates. The hypothalamus is crucial for vertebrate survival and is
composed of numerous small populations of neurons that collectively regulate a variety of important biological
functions. Dysregulation of the hypothalamus is linked to a number of disease states including neuropsychiatric
disorders, disorders of sleep, eating and metabolism, growth/development dysfunction, infertility, and more.
Because of its importance for organismal survival, the hypothalamus is the subject of extensive investigation
across multiple disciplines, using diverse techniques and in a variety of model organisms. In recent years,
scientists have made surprising advances in understanding the structure and function of the hypothalamus that
have generated many new questions and areas of investigation that require cross-disciplinary approaches.
The ultimate goal of this conference is to bring scientists together from a variety of disciplines to share and
discuss novel insights, experimental approaches, and therapeutic potential of recent findings. Because the
complexity of the hypothalamus is enormous, scientists study the hypothalamus at multiple levels of
investigation. Our program will have sessions on the role of the hypothalamus in a variety of health-related
behaviors including ingestive behaviors, sleep and circadian rhythms, and social interactions. Other sessions
will focus on hypothalamic plasticity, dissection of hypothalamic cell types, hypothalamic regulation of the
neuroendocrine system, and communication between the hypothalamus and organismal physiology. Taken
together, this GRC will allow for extraordinary interaction between scientists who study the hypothalamus
across many biological disciplines. As for all GRCs, the guiding principle of this meeting will be the
presentation of new, unpublished results with free, unencumbered discussion. We will emphasize participation
of scientists at all career levels, especially PhD students, postdocs, and junior faculty, with a particular focus on
promoting diversity and inclusion.

Public health relevance
PROJECT NARRATIVE The hypothalamus is a highly conserved region of the vertebrate brain that regulates vital survival functions including eating, drinking, sleeping, growth, development, fertility, stress, metabolism, and reward. Dysfunction of the hypothalamus causes a number of disorders and diseases that collectively cost billions of dollars for care and treatment. The goal of this interdisciplinary conference is to bring a diverse group of scientists together to showcase their latest findings, share insights and research strategies, and establish discussion and collaboration across fields.